National Health and Nutrition Examination Survey 2013-2014 Oral Health component

National Health and Nutrition Examination Survey 2013-2014 Oral Health component: 1. Detection of enamel fluorosis using quantitative imaging methods for surveillance purposes. 2. Assessment of periodontal disease prevalence and severity for surveillance purposes. 3. Assessment of dental caries prevalence and severity for surveillance purposes. 4. Testing of home water fluoride levels.